Collaborative Pediatric Critical Care Research Network - Clinical Site

ABSTRACT – University of Colorado Denver
With our participation in this iteration of the Collaborative Pediatric Critical Care Research Network (CPCCRN),
we contributed to a series of discoveries that enhanced our understanding of disease processes and resulted in
a multitude of potentially effective treatments for critically ill and injured children that require definitive evaluation
in clinical trials. There continues to be tremendous need for a collaborative research network in pediatric critical
care to facilitate the swift and effective translation of scientific and technologic discoveries into clinical advances.
Access to appropriate patients and expertise in the execution of clinical trials must be linked to scientists and
laboratories working within and across disciplines at the cutting edge of scientific advancement. At the University
of Colorado Denver (UCD) and Children’s Hospital Colorado (CHCO), we have a long history of successful
collaborative basic, translational, and clinical science programs focused on pediatric critical illness and injury.
We will provide several unique areas of strength to the CPCCRN, including: 1) a distinctive multidisciplinary team
of collaborative researchers with specific expertise in mechanistic investigations of cardiovascular and
pulmonary diseases, 2) a proven and successful track record as a clinical site in CPCCRN, 3) expertise with
pediatric clinical trials execution, including innovative programs to enhance positive research culture among
clinical staff and participation among patients and families, 4) a 7-state catchment area with high volumes of
critically ill and injured children, 5) an in-house rehabilitation program and extensive outpatient outreach program
capable of providing follow-up care to nearly all our critically ill patients, and 6) a dynamic partnership with the
Children’s Hospital Colorado Research Institute and Colorado Clinical Translational Science Institute to provide
extensive research resources. Our ancillary site, Arkansas Children’s Hospital (ACH) provides 1) experience
with pediatric clinical trials execution, including previous successful membership in CPCCRN 2) provision of care
to nearly all of the critically ill children from the State of Arkansas and a 4-state catchment area, 3) representation
of an Institutional Development Award (IDeA) state (historically received low levels of NIH support) and involving
their unique populations (rural, Marshallese, and medically underserved communities) in the NIH mission, and
4) a rich partnership with the ACH Research Institute and University of Arkansas Clinical Translational Science
Award to provide comprehensive research resources. Utilizing these assets, we will augment the contributions
of CPCCRN to the care of critically ill children through rigorous clinical trial execution, innovative translational
and clinical trial proposals, participation in CPCCRN leadership committees, and training the next generation of
pediatric critical care researchers. The proposed trial of “Personalized Immunomodulation in Sepsis induced
Multiple Organ Dysfunction Syndrome” is an incredibly innovative approach that moves beyond a “one therapy
for all” paradigm to an individualized therapeutic approach that will dramatically improve outcomes for children
with sepsis. We are enthusiastic and committed to participate in this project with the new 24-site CPCCRN.

Public health relevance
PROJECT NARRATIVE – University of Colorado Denver This proposal for the University of Colorado Denver/Children’s Hospital Colorado Pediatric Critical Care Program and our ancillary site, Arkansas Children’s Hospital, to participate in the CPCCRN describes our institutions’ commitment to pediatric critical care research and training junior investigators as well as the extensive capabilities, experience, investigations, and patient population which we will contribute to the network. Our institutions represent large geographically unique and diverse populations of children, which will ensure CPCCRN studies embody the diversity of our nation and the findings are generalizable to all critically ill and injured children.